MD/FAMILY PARTNERSHIP--EDUCATION IN ASTHMA SELF-MANAGEMENT

The purpose of this study is to develop and test an intervention based on theories of self-regulation of behavior in changing the diagnosis and treatment patterns and educational behavior of physicians who treat children with asthma. Physicians were randomized to intervention or usual care treatment condition.